GENETIC ANALYSIS OF THE MULTIDRUG RESISTANCE PHENOTYPE IN TUMOR CELLS

Cancer cells elude chemotherapy because of intrinsic or acquired changes in expression of specific proteins. We have studied resistance to natural product chemotherapeutic agents such as doxorubicin, Vinca alkaloids, and taxol, and to the synthetic drug cisplatin. In both cases, cells become simultaneously resistant to multiple drugs because of reductions in intracellular drug concentrations. For the natural product drugs this cross-resistance is due to expression of an energy- dependent drug efflux system known as P-glycoprotein (P-gp), the product of the MDR1 gene. For cisplatin, cross-resistance to methotrexate, some nucleoside analogs, and heavy metals is due to a reduction in drug influx resulting from a pleiotropic defect in uptake systems. Studies on mechanism of action of P-gp have focused on the manner in which many different substrates and inhibitors are recognized by the transporter, how substrate interaction results in activation of ATPase, and how ATPase results in drug translocation and efflux. We have made molecular alterations in various domains of the 12 transmembrane (TM), 2 ATP-site MDR1 transporter and characterize the effects of these mutations on transport function after high-level transient expression of P-gp in a vaccinia virus-based system in cultured cells. Functional chimeras of MDR1 and MDR2 have revealed that minor alterations in TM6 of MDR2 allow the N-half of MDR2 to support multidrug transport in an MDR1 backbone, demonstrating the importance of TM6 in determining substrate specificity. In addition, we have shown that a specific mutation in TM12 alters ability of MDR to recognize a specific class of substrates including flupentixol. Mutational and biochemical analysis of the two ATP sites demonstrates that both are essential, but their ATP binding and catalytic activities differ. These studies and others have led to the following major conclusions: (1) there are multiple, probably overlapping sites for interaction of substrates and inhibitors primarily formed by TM segments from both the amino-terminal (TM5,6) and carboxy-terminal (TM11,12) halves of P-gp; (2) substrate interaction sites include a high affinity [unreadable]on[unreadable] site, a lower affinity [unreadable]off[unreadable] site, and an allosteric site which affects ability of substrates to bind to the [unreadable]on[unreadable] site; (3) both amino- and carboxy- terminal ATP sites are essential for function of P-gp and the sites are partially interchangeable, but not identical; (4) both ATP sites are not utilized simultaneously, supporting a model of alternating activation of ATPase during substrate transport; and (5) activation of ATPase results in a reduction of substrate binding to P-gp, consistent with translocation of substrate from the [unreadable]on[unreadable] site to the [unreadable]off[unreadable] site. Use of the MDR1 gene as a dominant selectable marker in gene therapy has recently focused on the development of SV40 as a vector for delivery of MDR1. MDR1 can be efficiently packaged into SV40 vectors and delivered into hematopoietic cells. - Cisplatin, gene therapy, multidrug resistance, Phosphorylation, vaccinia virus, vectors, - Neither Human Subjects nor Human Tissues